Hexokinase 1 mitochondrial binding and its role in cardiac endothelial cell function and the development of HFpEF

Heart failure (HF) with preserved ejection fraction (HFpEF) is a prevalent disorder; however, our treatment
options are limited. Studies show that endothelial cell (EC) dysfunction precedes the development of HFpEF and
is a key player in the pathogenesis of this disorder. Hexokinases (HK) catalyze glucose phosphorylation, and
one HK isoform (HK1) binds to the outer mitochondrial membrane via its N-terminal hydrophobic domain,
encoded in its exon 1. We have generated a mouse model with deletion of the mitochondrial binding domain
(MBD) of HK1 (designated as ΔE1HK1 herein). These mice display HFpEF and reduced cardiac microvascular
density as they age, and isolated ECs show lower angiogenesis. Accordingly, ECs from mice with HFpEF display
increased HK1 mitochondrial dislocation, supporting that HK1 cellular localization plays an important role in the
development of HFpEF. Metabolomic studies on ECs from ΔE1HK1 mice showed that hexosamine biosynthetic
pathway (HBP) intermediates are decreased compared to WT mice. In addition, protein samples in ECs from
ΔE1HK1 mice showed less N-glycosylation of proteins, while increased post-translational O-GlcNAcylation was
observed compared to WT mice. These results suggest that HK1 dislocation causes a shift from protein N-
glycosylation to O-GlcNAcylation in ECs, and that this switch contributes to EC dysfunction and the development
of HFpEF. In this proposal, we will address the fundamental gap in knowledge of the mechanism of
HFpEF and whether increased protein O-GlcNAcylation in ECs contribute to the pathogenesis of this
disease. Our hypothesis is that HK1 mitochondrial dislocation leads to increased protein O-
GlcNAcylation and that HFpEF is associated with increased HK1 dislocation and higher protein O-
GlcNAcylation. We also hypothesize that a reduction in protein O-GlcNAcylation can reverse the
pathogenesis of HFpEF. In Aim 1, we will determine whether HK1 mitochondrial dislocation and increased
protein O-GlcNAcylation in ECs cause EC dysfunction and angiogenic defects. We will inhibit protein O-
GlcNAcylation with O-GlcNAc transferase (OGT) inhibitors or “force” HK1 to the mitochondria in ECs from WT,
ΔE1HK1 mice and mouse models of HFpEF and will assess their angiogenic potential. In Aim 2, we hypothesize
that O-GlcNAcylation of histones are increased in ECs from HFpEF hearts. To test this hypothesis, we will
perform mass spectrometry (MS) on the cellular, cytosolic and nuclear fractions of ECs from HFpEF and ΔE1HK1
mice. We will also perform ChIP-Seq and RNA-seq in ECs from WT, HFpEF and ΔE1HK1 mice to determine the
differential gene expression in HFpEF. In Aim 3, we will determine whether inhibition of protein O-GlcNAcylation
reduces the progression of HFpEF. We have crossed the ΔE1HK1 mice with mice that overexpress O-
GlcNAcase (OGA, an enzyme that opposes OGT and reduces protein O-GlcNAcylation) in ECs and will assess
cardiac function in these mice. Additionally, we will assess whether treatment of mice with a novel OGT inhibitor
reverses the progression of HFpEF, providing a clinical relevance for our studies.

Public health relevance
Project narrative Heart failure with preserved ejection fraction (HFpEF) is a common disorder, but our treatments for this disorder are limited. We have generated a mouse model in which the enzyme that phosphorylates glucose (i.e., hexokinase 1) cannot bind to the mitochondria, and have shown that these mice develop HFpEF and display dysfunctional endothelial cells in their hearts. In this proposal, we will study the mechanism for the endothelial dysfunction in these mice and will study novel therapies for HFpEF.